New York Regional Center for Diabetes Translation Research

CENTER OVERVIEW
The New York Regional Center for Diabetes Translation Research (NY-CDTR) is seeking is first
competitive renewal in order to continue to maximize the assets devoted to diabetes translation research in the
high-need, culturally diverse New York area. With this application, we expand our services and enhance our
focus on health equity and social determinants of health. The NY-CDTR greatly expands the resources to
support type 2 translational research on diabetes and obesity and foster further collaborative efforts to drive
cutting-edge translational research throughout the New York region, with the Albert Einstein College of
Medicine serving as a central collaborating hub for these efforts. Our National Resource Core enhances our
impact on the national level with a focus on diabetes prevention and control in the US Latino population. The
intrinsic strength of our multidisciplinary research base and diversity of patient- and community-centered
activities provide an integrated platform upon which the NY-CDTR has developed and will continue to expand
strong linkages, leveraging our several NIH-funded Centers and institutional resources. The goals of the NY-
CDTR are to continue to improve and expand delivery of existing services, develop innovative new services
and increase the breadth of our translational research base to focus on health equity and T3-T4 translational
research projects targeting diabetes health equity in vulnerable populations in collaboration with multi-sector
and multi-stakeholder partners. Our growth in membership, productivity in outcomes, and our research base
over our first funding period positioned us extremely well for continued national impact. Guided by our Center
themes that focus on health equity and a biopsychosocial approach, we focus on these Specific Aims:
1) To foster the growth and development of an existing outstanding scientific base devoted to type 2
translational research related to the prevention and control of diabetes and its complications by supporting and
administering four translational research cores, including a National Resource Core: a) Behavioral Science
and Technology Core, b) Life Course Methodology Core, c) Population Health and Health Systems
Core, d) Latino Network for Diabetes Translation Research: A National Resource Core. 2) To promote a
Pilot & Feasibility Study Program that supports initiation of diabetes translation research programs and
enhances the careers of new investigators. 3) To support and organize an Enrichment Program by making
accessible outstanding, live and virtual, interactive, external and internal seminars, podcasts, faculty/trainee
conferences. 4) To provide an Administrative Core as the principal means of planning, implementing and
evaluating the programs in research, training, resources and enrichment activities. 5) To expand and integrate
the scientific efforts of the NY-CDTR with our innovative Latino Network for Diabetes Translation Research
national resource core that engages investigators leading the NIH-funded Hispanic Community Health
Study/Study of Latinos and others funded for Latino diabetes translation research.

Public health relevance
Public Health Relevance The New York Regional Center for Diabetes Translation Research (NY-CDTR) has relevance to public health for three important reasons, the first being that much of our work is focused in the New York City metropolitan area, which is a population-dense, urban area with documented health and health care disparities for diabetes and obesity. Second, this region is home to various academic, health care system, public health resources, and community based organizations focused on health, thereby providing a strong platform for cutting-edge translational research; and third, the research base of the NY-CDTR is focused on diabetes translation research that can be sustainably implemented in diverse healthcare and community settings, and is designed to reach the underserved and disadvantaged.